Interaction of mitochondrial fusion and transmembrane potential in diabetic cardiovascular damage

PROJECT SUMMARY/ABSTRACT
This proposal explores the interaction of mitochondrial fusion dynamics and transmembrane potential
(∆ψm) as an underlying mechanism and translational target in diabetic cardiovascular damage. Type 2
diabetes mellitus is a rapidly-increasing public health concern, causing decreased cardiac efficiency
which is the leading cause of mortality among Type 2 diabetics. A range of clinical and experimental
data suggests that the cytokine-mediated inflammation that drives diabetic pathology directly damages
mitochondria, the organellar network responsible for cellular bioenergetics. Crucially, however, it is
unknown what level of mitochondrial damage can be sustained in highly-oxidative cardiac cells before
pathology ensues. Our current SC3 support has provided novel mechanistic insights motivating the
proposed aims: 1) to explore how the OMA1 stress-responsive protease is activated by loss of ∆ψm, 2)
the role of OPA1 levels in determining mitochondrial fusion homeostasis, and 3) the time-dependent
nature of ∆ψm-sensitive mitochondrial fusion dynamics. These experiments will leverage our published
cell-based imaging and functional assays to further explore this gap in knowledge. To maintain
bioenergetic homeostasis, mitochondria balance their organization between a united, reticular network
(OPA1-mediated fusion) and a fragmented population of individual organelles (DRP1-mediated fission).
The ∆ψm across the mitochondrial inner membrane is required for mitochondrial fusion, linking
organellar function and structural dynamics: we demonstrated previously that a sharply-defined
threshold of 34% ∆ψm is required for mitochondrial fusion. Strikingly, our current data indicates that a
similar threshold exists in cardiac-derived cells, and that this threshold is mediated by OMA1, a stress-
response protease that cleaves the mitochondrial OPA1 fusion protein in response to low ∆ψm. Further,
our data suggests that novel intramolecular domains are required for OMA1 to sense loss of ∆ψm. Our
project will mechanistically explore this threshold, as well as the impacts of cytokine-mediated damage
on ∆ψm and fusion dynamics and the time-integrated nature of mitochondrial stress-sensitive dynamics.
This research has strong potential to inform a novel translational approach to protect cardiac
mitochondria against cytokine-mediated damage.

Public health relevance
PROJECT NARRATIVE Decreased cardiac efficiency is a major complication of Type 2 diabetes and is the leading cause of death among diabetics. While mitochondria, the organelles providing energy to the cell, have long been implicated in both diabetes and cardiovascular disease, emerging research indicates that the increased inflammation that causes Type 2 diabetes disrupts mitochondrial structure/function homeostasis in the diabetic heart. The proposed research will critically examine an emerging mechanism of mitochondrial structure/function homeostasis, uncovering the mechanistic impacts of cytokine-mediated inflammation, with major potential for discovering novel therapeutics to protect cardiac mitochondria from inflammatory damage. The proposed aims will directly support development of the P.I.’s research program and increase under-represented student access to research careers at a major Hispanic-serving institution.